Identifying Developmental and Degenerative Mechanisms of SMA Using Single Motor Neuron Nucleus RNA Sequencing

PROJECT SUMMARY
Spinal muscular atrophy is a monogenic motor neuron disease and is historically a leading inherited cause
of death in infancy and childhood. While development of SMN-dependent therapies has significantly
improved patient outcomes, continued neurological deficits in most patients highlights the need for SMN-
independent therapeutics to improve motor neuron (MN) function and survival. This effort is hindered by
the lack of understanding of how SMN deficiency impacts MN development and degeneration. Our
laboratory recently demonstrated that severely impaired proximal motor axon radial growth beginning at
mid-late embryogenesis and rapid degeneration of the entire MN postnatally are prominent features of
type I SMA patients, but the molecular mechanisms driving these cellular events and the importance of
these pathologies to milder forms of SMA are unknown. Historically, it has been difficult to obtain
transcriptomic data from MNs in vivo due to their sparseness within the spinal cord, and while in vitro
models can provide detailed transcriptomic data, these models forgo MN heterogeneity and the
complexity of the spinal cord environment. To circumvent these difficulties, we have collaborated with
Dr. Le Pichon at the NIH to produce two SMA mouse models that express GFP-tagged Sun1, a nuclear
envelope protein, in choline acetyltransferase (ChAT) positive neurons of the spinal cord for FACS
sorting and subsequent single nucleus RNA sequencing (snRNAseq). Using snRNAseq, we aim to
elucidate the aberrant developmental pathways that drive early stages of SMA pathogenesis, and further
compare the magnitude and temporality of the identified mechanisms in severe and mild models of SMA.
We aim to do this by characterizing and performing snRNAseq on two SMA mouse models, the severe
model (Smn-/- SMN2+/+) and a mild model (Smn2B/-). Each model will be behaviorally and histologically
characterized in Aim 1 to identify appropriate time points for snRNAseq in Aim 2. In Aim 3, genes and
pathways of interest will be validated using qRT-PCR, in situ hybridization, and protein quantification in
both mouse models and in human autopsy tissues. Together, these studies aim to identify shared and
divergent developmental and degenerative mechanisms across the spectrum of disease severity to inform
future therapeutic development.

Public health relevance
PROJECT NARRATIVE Spinal muscular atrophy (SMA) is a genetic, neuromuscular disease that causes early onset, severe muscle weakness. While SMA patient outcomes have significantly improved since the development of SMN- increasing therapeutics, neuromuscular deficits are still present in most patients. The objective of this project is to identify mechanisms of SMA motor neuron maldevelopment and degeneration in mouse models with differing disease severity to guide future therapeutic development and improve patient quality of life.